Regulation of the Innate Immune Response by the Epithelium in Asthma

It is well known that infection by respiratory viruses (e.g., RSV or RV) can exacerbate responses in individuals who are allergic asthmatics. It is our hypothesis that the airway epithelium is the central coordinator of responses to respiratory virus infection, as well as to allergens. Intrinsic differences in airway epithelial cells (AEC) in healthy and asthmatic individuals play an important role in this exacerbated response. AECs from asthmatics respond in a different manner to infection than AECs from healthy subjects. These differences are manifested during infection in several ways, including changes in the expression and deposition of extra cellular matrix components and qualitative and quantitative differences in the expression of cytokines and chemokines. This altered response in asthmatic AEC leads to changes in both innate and adaptive responses during infection, with increased infiltration of the airways with leukocytes. The primary goal of this Program is to identify and characterize these changes in asthmatic AECs, and determine their effects on the innate and adaptive immune response. With this goal in mind, we will (1) Determine the role of the epithelium in regulating ECM and leukocyte adhesion in viral-triggered asthma; (2) Determine the regulation of the Innate Immune response by the epithelium in asthma; (3) Determine the role of the epithelium in regulating T cell responses in asthma.

Public health relevance
The airway epithelium is the point of first contact for the lungs with the outside world. In this context it is critically important to understand its role in infection by SARS-CoV2 and the development of COVID-19. To gain a better understanding of these processes we will take advantage of unique resources available within our AADCRC Program to examine differences between healthy and asthmatic epithelium, and to identify host genes that are involved in infection and replication of the virus. The studies in this supplement proposal will provide important new data on potential therapeutic pathways to treat this disease.